The Development of Novel Anion Receptors for Reactive Sulfur, Oxygen, and Nitrogen Species

Project Summary
Gasotransmitters, such as H2S and NO, are small molecule bioregulators that are responsible for
regulating different aspects of physiological functions and cellular signaling. The crosstalk between these and
related biologically active species can lead to the formation of reactive sulfur species (RSS), reactive nitrogen
species (RNS), and reactive oxygen species (ROS), which have their own roles in physiological mechanisms.
Although often written as a neutral species, H2S and other reactive sulfur, nitrogen and oxygen species are
typically anionic under physiological conditions. Anionic reactive sulfur, oxygen, and nitrogen species (ARSONS)
are short-lived, small molecule intermediates formed by the crosstalk between gasotransmitters and other
physiologically relevant species. Molecular crosstalk between NO and H2S leads to the formation of SNO– and
SSNO– which have their own physiological roles in crosstalk and cell-signaling processes. The complexity and
reactivity of these small reactive species in biological environments make understanding their interconnectivity
and specific involvement in signaling pathways incredibly difficult. My proposed research will investigate methods
of molecular recognition to target RSS, RNS, and ARSONS as an understudied class of anionic targets with the
more long-term goal of understanding specific molecular environments that stabilize these reactive species.
The long-term goal of this research is to develop new tools for the molecular recognition of ARSONS. In
a recently submitted manuscript, I have been able to demonstrate through a diverse library of C–H hydrogen
bonding based receptors that vary in charge, directionality, and preorganization that HS– and NO2– can be bound
and that these receptors exhibit a particular preference for forming strong C–H⋯S interactions. We noted that
the macrocyclic receptors exhibited much stronger binding affinities compared to non-macrocyclic analogues.
Inspired by these strong hydrogen bonding interactions and the driving force of preorganization, we now first
focus on using C–H and N–H based macrocycles, cryptands, and cages to further investigate RSS, RNS, and
ARSONS. Additionally, I will also investigate how anion-p interactions can stabilize these reactive species. These
host compounds are comprised of electron deficient p-systems capable of binding anions and vary in flexibility
and complimentary binding motifs. Finally, I will use the insight gained the previous experiments to rationally
design novel anion receptors specific for binding ARSONS. The iterative feedback gained from the other hosts
will provide new information on how cooperative interactions can target different functional groups present in
ARSONS. Completion of this work will aid in the development of new tools to investigate biologically relevant,
reactive anions and has the longer-term potential to inform on mechanisms and pathways related to molecular
crosstalk and cellular signaling of these under-investigated species.

Public health relevance
Project Narrative Small molecule bioregulators are reactive species that are utilized by biology to regulate physiological functions through cellular signaling and molecular crosstalk. For some of these species, such as SNO– and SSNO–, the interconnectivity and their involvement in biological signaling pathways are still poorly understood due to their complexity and high reactivity in biological systems. This project will provide insight into how these reactive species can be stabilized which can inform on the reactivities and pathways these molecules engage in in physiological conditions.